Towards High-Resolution Neuro-Behavioral Quantification of Sheep in the Field to Study Complex Social Behaviors

Abstract
Social animals, including humans, engage in complex collective behaviors in the field. While
there are simple models of collective decision making and movement that are amenable to
study in traditional laboratory environments, they inevitably fail to capture the full complexity
of natural behaviors as they occur in the field. Moreover, standard mammalian laboratory
species either exhibit only simple social behaviors (e.g., mice) or are too challenging to house
in large groups (e.g., primates). Here, we will leverage decades of extensive experience
studying sheep in their normal pasture settings and during interactions between ewes and
their lambs. We propose to develop a paradigm for acquiring high resolution (in space and
time) measurements of individual herd members, including head-mounted devices to sense
their visual sensorium. We will test these devices in existing herds maintained for agricultural
study, while also developing a robust paradigm for conducting neural recording experiments.
If successful this work will lay the foundation for future study of the neural circuits underlying
complex collective behaviors in a large-brained highly social animal model.

Public health relevance
Project Narrative This proposal seeks to lay the groundwork for conducting large scale neural recording experiments in herds of sheep engaging in their normal individual and collective behaviors in the field. We will develop new embedded systems which enable high spatio-temporal resolution tracking of individual behavior as well as measurement of the visual sensorium of the animals. With this cutting-edge data, we will develop a new generation of computational models that predict individual behavior based on internal state dynamics and perception of the environment and the behavior of conspecifics.